SMART Therapist Training: A Hybrid Factorial-SMART Design

Background: One third of post-9/11 Veterans in VHA suffer from posttraumatic stress disorder (PTSD), and
even among those who receive evidence-based PTSD treatment, over half remain symptomatic. Cognitive
Processing Therapy (CPT) is a first-line treatment for PTSD that is initiated three times more frequently than
any other trauma-focused treatment. CPT is highly effective in randomized controlled trials, but its
effectiveness drops substantially in standard clinical practice, largely due to therapist “drift” from fidelity to the
protocol. What remains unknown is which components of CPT training yield high therapist fidelity. Thus, there
is a critical need to use empirical approaches to identify the most effective components of CPT training and to
develop an adaptive training model for CPT by testing sequences of empirically-supported training strategies.
The long-term goal of this research is to develop a sustainable model of therapy training that is personalized to
the needs of the therapist trainee. The overall objective of this application is to empirically optimize an adaptive
model for CPT training. The rationale is that developing an adaptive training model will improve efficiency and
personalization, yield higher fidelity, and ultimately improve Veteran outcomes. We expect that completion of
this project will produce an adaptive CPT training program that yields high therapist fidelity. Improving CPT
fidelity in VHA will have a positive impact on the health and wellbeing of Veterans with PTSD.
Significance: The number of VHA patients with a diagnosis of PTSD has steadily increased for the past 10
years, therefore improving VHA's capacity to deliver PTSD treatment is of utmost importance. This project
aligns with the 2024 VHA priorities to connect Veterans to the best care and improve VHA workforce retention.
Innovation & Impact: Upon successful completion of this project, we expect to contribute an empirically-
based, adaptive training model for CPT. This contribution will improve therapist fidelity to CPT and ultimately
yield superior clinical outcomes for Veterans with PTSD. The proposed research is innovative because it will
use a novel, highly efficient experimental design to shift the current CPT training paradigm from fixed, hard-to-
scale strategies to a dynamic and accessible approach, composed of empirically-based components.
Specific Aims: Specific Aim 1: Identify which of two low-intensity training components contribute
meaningfully to therapist fidelity. We will test the effectiveness of each component and their interaction, as
measured by therapist fidelity ratings across 12 months. Specific Aim 2: For those with “fidelity in
progress,” determine whether stepping up to high-intensity consultation improves fidelity. We
hypothesize that stepping up will lead to greater fidelity. Exploratory Aims: A) For those with “early fidelity,”
assess the impact of stepping down to self-monitoring versus continuing in standard consultation. B)
Compare standard training and consultation to the embedded adaptive training strategies. C) Identify
moderators. D) Conduct cost analysis and refine the program through process evaluation.
Methodology: This Hybrid Factorial-SMART will determine which of two low-intensity components (Web-
based Training or Consultation Work-Sample Review) is most effective during the initial phase of training.
Those who have reached fidelity benchmarks at Month 4 (“early fidelity”) will be re-randomized to Continue
with standard consultation or Step Down to fidelity self-monitoring. Those not reaching fidelity at Month 4
(“fidelity in progress”) will be re-randomized to Continue or Step Up to high-intensity consultation. Fidelity will
be assessed by trained evaluator at baseline, 6, 9, & 12 months via standardized patient exercise. Secondary
outcomes include Veteran PTSD symptoms, therapy attrition, and Veteran-therapist working alliance.
Next Steps/Implementation: We will interview participating therapists to refine the program and identify
determinants of future implementation. Pending demonstration of effectiveness, our partners in the Office of
Mental Health and Suicide Prevention will work with us to support implementation efforts across the system.

Public health relevance
The proposed research will develop an adaptive therapist training program using empirical methods. This project is relevant to Veterans' health because it will improve training effectiveness, yield higher therapist fidelity to protocol, and lead to better symptom outcomes for Veterans who receive treatment. This proposal is directly responsive to the 2024 HSR implementation science priorities to use SMART designs to develop adaptive implementation strategies. It also aligns with the engagement science priorities and specifically the Provider Engagement/Workforce priorities to (1) assess the impact of health care workforce programs on Veteran outcomes with a focus on novel approaches to develop clinical capacity among frontline staff, and (2) conduct interventional studies of system level interventions to improve workforce well-being by enhancing training opportunities. It aligns with the priorities of the Mental Health HSR Topic Area to enhance quality of mental health services and promote use of evidence-based practices, focused on the priority topic of PTSD.